Antigen-specific T cells in immunotherapy-associated acute kidney injury

Project Summary
Kidney inflammation contributes to chronic kidney damage, fibrosis and end-stage kidney diseases. Adaptive
immune responses are tightly regulated in kidney to prevent excessive inflammation and to maintain self-
tolerance. However, infections and medications can break self-tolerance and trigger autoimmunity.
Immunotherapy has become a standard therapy for many cancers, but it can cause autoimmune kidney
adverse events, including acute kidney injury and glomerulonephritis. Acute interstitial nephritis is the most
common immunotherapy-associated acute kidney injury, characterized by immune cell infiltration in kidney.
Our group showed it affects 2-3% of the patients receiving immunotherapy, resulting in significantly increased
mortality and risk of progression to chronic kidney disease. While immunotherapy-associated acute kidney
injury responds to corticosteroids, non-specific immunosuppression also blunts the tumor immune response.
Thus, understanding the mechanisms of immunotherapy-associated acute kidney injury and developing
targeted therapies that uncouple tumor- and kidney-immune response is critical to improve patient outcomes.
Our overall goal is to identify antigenic and immunological drivers of immunotherapy-associated kidney-
immune response. Kidney-associated antigens have been identified as targets of autoimmune kidney
diseases, such as in membranous nephropathy and podocytopathies. Our data support that antigen-specific T
cells also play a critical role in immunotherapy-associated acute kidney injury. Immune cell phenotype and
tissue microenvironment are key determinants of inflammation: abundance of effector T cells among kidney-
infiltrating lymphocytes is associated with severe kidney inflammation, whereas regulatory T cells (Treg) are
associated with tolerance. Inflammatory tissue microenvironment and chemokines are key drivers of
lymphocyte trafficking to kidney. However, detailed mechanisms to control effector T cells, Treg and kidney
tissue microenvironment in immunotherapy-associated acute kidney injury is not well understood. This project
aims to understand the roles of antigen-specific effector T cells (Aim 1), regulatory T cells (Aim 2) and kidney
tissue microenvironment (Aim 3) in immunotherapy-associated acute kidney injury, using our novel mouse
model, which expresses a series of model antigens in a kidney tubule-specific manner. This unique model will
provide an ideal platform to delineate the phenotype and function of antigen-specific T cells in immunotherapy-
associated acute kidney injury. By using novel, innovative approaches to study antigen-specific immune
response in immunotherapy-associated acute kidney injury, we will better understand the mechanisms of
immunotherapy-associated acute kidney injury, and will identify novel therapeutic targets for immunotherapy-
associated acute kidney injury. This project will ultimately advance our fundamental knowledge of kidney
immunobiology and bring new insights into the mechanisms of other forms of autoimmune kidney diseases.

Public health relevance
Project Narrative Immunotherapy has become a standard therapy for many cancers, but it is associated with a risk of acute kidney injury, resulting in significantly increased mortality. Overall goal of this study is to delineate the roles of antigen-specific T cells in immunotherapy-associated acute kidney injury, using novel animal models. The study will lead to better understanding of the mechanisms of immunotherapy-associated kidney injury and identification of potential therapeutic targets.